Component 1 Admin Core Savage - Valenzuela

PROJECT SUMMARY – ADMINISTRATIVE CORE
NMARC's Administrative Core is responsible for providing scientific and administrative leadership for the entire
center program along with the administrative support and budgetary oversight of all NMARC-related activities.
Operational supervision of the NMARC is provided by a three-tiered system of management: 1) The Admin Core
Executive Committee. 2) The NMARC Steering Committee, composed of four directors and senior researchers
from UNM and the MIND Research Network. 3) The NMARC Program Advisory Committee (PAC) composed
of seven internationally renowned FASD research investigators. The Admin Core has four specific aims: Aim
1) Provide administrative leadership and support for the NMARC. All NMARC investigators receive routine
administrative support. The Admin Core also arranges all NMARC-related meetings, manages logistical
arrangements for NMARC seminar visitors, the Annual FASD Day Symposium, and the Annual NMARC Meeting
with the PAC. The Steering Committee meets twice a year to review progress on the research components and
discuss any resource allocation issues. The Steering Committee also meets with the PAC during the Annual
NMARC meeting to discuss each research component's progress, the operation and coordination of the
Administrative and Pilot Project cores, and the center's overall progress towards the achievement of the specific
aims of the center as a whole. Aim 2) Provide scientific leadership and direction to NMARC's investigators,
working to help them achieve the specific aims of their individual projects while advancing the specific aims of
the center as a whole. The Admin Core will facilitate collaborative research interaction and communication
through the monthly NMARC Investigator Group meetings with all NMARC-affiliated investigators, working to
increase the integration of preclinical and clinical research projects. The Admin Core will also work to build
NMARC's research capacity through oversight of the pilot project program, continued efforts to recruit new faculty
investigators to NMARC, building research collaborations with other institutions and encouraging the training of
future FASD investigators. Aim 3) Manage all issues related to resource allocation within the NMARC and strive
to maximize the synergistic utilization of research resources within the center. The Admin Core will coordinate
and facilitate NMARC investigator access to other resources within the university. Aim 4) Enhance our
knowledge dissemination capabilities through our NMARC Seminar Series, the Annual FASD Day Symposium,
a NMARC Webpage, and expanding our community outreach activities. Assessment of NMARC's progress
towards the achievement of these aims and the strategic objectives is the responsibility of the Steering
Committee working in conjunction with the PAC.